Characterization of Allogeneic T Cells Mediating HIV Cure

PROJECT SUMMARY
With the most people ever in history currently living with HIV, stopping the HIV epidemic remains imperative.
Combination antiretroviral therapy (ART) limits viral replication, but is not curative. Thus, there is an urgent need
to design a functional cure via elimination of the viral reservoir. Five individuals, Timothy Brown (Berlin Patient),
Adam Castillejo (London patient), Paul Edmonds (City of Hope patient), Marc Franke (Düsseldorf patient), and
the New York City patient who has not released their identity were cured of HIV following leukemia-related, MHC-
matched, allogeneic hematopoietic stem cell transplantation (alloSCT). How alloSCT mediates cure of HIV is
unknown. Using our alloSCT model in Mauritian cynomolgus macaque (MCM), we have demonstrated that the
allogeneic immune response can potently purge the latent reservoir. Therefore, we hypothesize that allogeneic
T cell responses targeting minor antigens mediate HIV cure similar to how they mediate cure of leukemia. We
propose here to define the allogeneic T cell responses in both the individuals who were cured of HIV, as well as
the two MCM cured of SIV following alloSCT. In specific aim 1, we will define the allogeneic T cell responses
and their targets in three of the individuals cured of HIV (Adam, Paul, and Marc), as well in a number of other
cases where individuals underwent alloSCT and experienced a disappearance of HIV from the blood. In specific
aim 2, we will define the allogeneic T cell responses and their targets in the two MCM cured of SIV post alloSCT,
as well as in a further longitudinal cohort of SIV+ MCM that underwent alloSCT and experienced a decrease in
the viral reservoir. In aim 3, we will adoptively transfer T cells expressing human or MCM allogeneic T cell
receptors into HIV+ humanized mice or SIV+ MCM, respectively, to measure the safety and efficacy of allogeneic
T cells for HIV cure. This work would expand our knowledge of the mechanism of HIV cure in the setting of
allogeneic HSCT and establish a new therapeutic approach for HIV cure.

Public health relevance
PROJECT NARRATIVE The development of curative approaches for HIV infection is now recognized as both a necessary and attainable goal. Hematopoietic stem cell transplantation has been shown to cure HIV infection in five separate patients, but the allogeneic immune responses are not defined. We propose here to define the allogeneic immune responses targeting minor histocompatibility antigens in both individuals cured of HIV and macaques cured of SIV via allogeneic stem cell transplantation.